Biostatistics

Project Summary/Abstract
The purpose of Core 4 Biostatistics is to provide statistical support to all the Projects in this P01. For the
association between clinical outcome and the comprehensive molecular and proteomic dissection of Richter's
syndrome (RS), as performed by Project 1, the Core will assemble and curate the clinical data provided by
internal and external collaborators and perform all analyses of association between these novel findings and
appropriate clinical parameters. This will include working closely with Project to assess in cfDNA any RS-specific
alternations that may predict this transformation. For all laboratory and animal studies of Projects 2 and 3, the
Core will assure that the design, conduct, and analysis of experiments use robust statistical techniques that are
appropriately implemented. For Project 2 this includes the single cell analyses of the tumor-intrinsic and tumor-
extrinsic features, as well as the longitudinal assessment of these features. The mice developing RS with
combinations of common CLL mutations (generated through this P01) will be assessed for response and
resistance to novel therapies and analyzed by this Core. DBP studies are performed through Project 3, and the
use of the Core for clinical association will permit Project 3 to remain blinded to clinical outcomes when
performing their assays, assuring an unbiased assessment of their predictive ability. Through these aims, this
central resource for the Projects will coordinate our insights into the trajectories from CLL to RS and support our
ability to identify rational and personalized therapeutic strategies that will offer patients an improved chance of
cure.

Public health relevance
PROJECT NARRATIVE - Core 4 Biostatistics The goal of Core 4 Biostatistics is to assure that all experiments conducted through this P01, centered around chronic lymphocytic leukemia and Richter's Syndrome, have access to state-of-the-art statistical support for their design and analysis. This extends to the basic science and murine experiments described as well as to the clinical and correlative studies undertaken by all the Projects, as well as the Cores. This assures that the work performed on this P01 will be robust and reproducible, and thereby contribute to an improved understanding of these diseases.